Administrative Core

Administrative Core Summary
The purpose of the Administrative Core is to provide administrative and managerial support to the entire LJI's
HIPC program to facilitate progress, foster effective communication and coordination both within LJI and with
NIH, and catalyze effective use of resources. In parallel, the Administrative Core will ensure that all Projects and
Cores adhere to scientific, fiscal, and NIH reporting and communication objectives. These functions will be crucial
for the successful execution of the work outlined in this proposal, given the number of Cores and Projects
participating, the extensive sharing of data and methodologies between each Project, and the timelines put forth
from the team. Though each Project will individually provide important information to the broader HIPC network
through their research findings, extensive synergistic efforts are required to carry out the full scope of the overall
Program.